Selenoprotein-independent biological roles for selenium in selenium deficiency and excess

Project Summary
Selenium (Se) is an essential micronutrient with antioxidant function as it is required in the synthesis of 25
different selenoproteins, many of which are antioxidants such as glutathione peroxidases. Observing that
selenium’s antioxidant effects are too rapid and robust to be explained by selenoprotein production alone, we
uncovered a novel biological mechanism for selenium, in which it acts as an electron donor to reduce ubiquinone
to ubiquinol in a reaction that is catalyzed by sulfide quinone oxidoreductase (SQOR). Ubiquinol is a key redox
component in mitochondria, as well as a cellular respiration intermediate, and this mechanism allows selenide
to rapidly suppress lipid peroxidation and trigger cellular respiration. Based on strong preliminary data, we will
examine the hypothesis that this mechanism allows selenium to act as a powerful antioxidant as well as an
alternative electron transport fuel. This mechanism is expected to account for some of the previously known
cytoprotective properties of selenium, explain why selenium deficiency is harmful, as well as introduce novel
selenium-based therapeutic approaches. In Aim 1, we will examine the role of SQOR-catalyzed ubiquinol
formation in the antioxidant role of selenium, as well as its previously unappreciated role as an electron transport
fuel. The beneficial effects of this mechanism on cell-based disease models for cardiomyocyte ischemia, electron
transport dysfunction, and ETC-impairing environmental toxins will be examined. In Aim 2, we will examine the
hypothesis that excess activation of this ubiquinol, membrane-polarizing mechanism is responsible for the
toxicity of high selenium levels. In Aim 3, we will explore the notion that the form of selenium as well as the
delivery route in vivo is key in whether this novel SQOR / ubiquinol mechanism is engaged. The proposal will
result in a mechanistically enhanced understanding of the biological roles of selenium and introduce strategies
to harness selenium biology for therapeutic effects.

Public health relevance
PROJECT NARRATIVE This project will explore a mechanism we have uncovering by which selenium exerts its biological effects in a mechanistically distinct from its ‘textbook’ role of producing selenoproteins. Our findings indicate that selenium can also donate its electrons to ubiquinol and that this is a rapid mechanism by which selenium can counter oxidative stress and restore electron transport chain activity, expanding what is known about selenium in biology. We will explore how this mechanism can protect against cell death in models for various disease contexts including heart attacks, mitochondrial disorders, and environmental toxin exposure.